Administrative Core

PROJECT SUMMARY/ABSTRACT (Administrative Core)
The University of Michigan (U-M) is a leader in interdisciplinary translational research, and this is especially true
for the field of autoimmune skin disease. The study PIs have built an impactful translational research program in
systemic lupus erythematosus (SLE) and cutaneous lupus erythematosus (CLE) that integrates a well characterized patient cohort coupled with expertise in skin biology, autoimmunity, immunology, and state-of-the art bioinformatics analysis. Despite these successes, there are untapped opportunities to build further research
synergy and progress in the stromal-immune interface that contributes to disease. These needs include the study
of connectivity networks in the skin, the role of immune memory on disease, and the etiology of photosensitivity.
The proposed Integrated Program in Cutaneous Immune-Stromal interactions in SLE (IPCISS) will provide
investigators the opportunity to expand and synergize their research, access a state-of-the-art Research Core,
and enhance a vibrant, integrated skin and rheumatic disease research community through outstanding
enrichment programs. The ultimate goals of the Program are to: 1) develop sufficient knowledge of the
pathogenesis and triggers of CLE in SLE patients to facilitate novel treatment approaches in this difficult to treat
disease; and 2) incorporate the highest yield translational and state-of-the-art omic approaches in SLE skin
disease investigation. The U-M IPCISS Program will achieve these goals through two research projects focused
on 1) the role of stromal/immune interaction in disease and treatment response and 2) the stromal/immune
interactions that contribute to aberrant ultraviolet (UV) light responses and initiation of disease. It will also
establish a state-of-the-art Scientific Core, the Bioinformatics and Integrated Omics Pipeline for Stromal and
Immune Interaction (BIOPSII) Core, which is designed to provide innovative, in-depth services and training to
Program participants and collaborators. The IPCISS Administrative Core will coordinate Programmatic activities
and oversee management of the Projects and Research Core, with the following specific aims: 1) Provide
leadership and oversight for the IPCISS; 2) Develop and enact effective Center management strategies; 3)
Effectively disseminate information regarding the IPCISS findings to a broad constituency that encompasses
patients, clinicians, and scientists through a strong communication platform; 4) Build and administer a robust
Enrichment Program to enhance the goals of the IPCISS. This will include a quarterly Visiting Speaker Series,
an Annual Symposium, and a Patient Recruitment and Education Program to promote patient engagement in
research. As a result of these Center activities and the outstanding science conducted by the Projects and the
BIOPSII Core, the IPCISS will have a powerful and sustained impact on lupus disease research at U-M and
beyond.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE Skin lesions associated with cutaneous and systemic lupus are triggered by exposure to sunlight, are difficult to treat, and result in poor quality of life and increased health care costs for patients. The University of Michigan Integrated Program in Cutaneous Immune-Stromal interactions in SLE (IPCISS) will focus on implementing novel technologies and analysis strategies to 1) study the stromal and immune cellular interactions that drive persistent inflammation and 2) the communication mechanisms and cellular players critical for sensitivity to ultraviolet light. This Program, coupled with the training and mentorship, scientific discourse, and patient education, will achieve the NIH’s mission to foster fundamental discoveries and their applications to protect and improve public health, with a specific focus on lupus and its associated skin disease.